LIGHTSITE IIIB: Clinical Evaluation of Photobiomodulation (PBM) in dry AMD Patients

ABSTRACT
As the population continues to age, degenerative ocular diseases become increasingly common
and create tremendous burden on the health care system. Age-related macular degeneration (AMD)
is a progressive ocular disease that causes visual impairment and blindness in its most advanced
form and is characterized by loss of function and cell death in the macula, a central and critical
part of the retina. Approximately 11 million individuals are affected with AMD in the United
States alone, with a global prevalence of 170 million. AMD is the leading cause of visual disability
in the developed world and the third leading cause globally. AMD occurs in two forms: dry and
wet AMD. Approximately 85-90% of AMD patients have the “dry” form of the disease.
Photobiomodulation (PBM) is a low-level light therapy used to induce beneficial cellular processes
resulting in significant clinical outcomes, including tissue repair, tissue regeneration and anti-
inflammatory effects. At the cellular level, the mechanisms of PBM are ascribed to activation of
mitochondrial respiratory chain components resulting in stabilization of metabolic function.
LumiThera, Inc. has developed the Valeda® Light Delivery System which delivers
multiwavelength PBM for ocular indications. Multiple studies with Valeda now demonstrated
improvements in quality of life, clinical, and anatomical outcomes in dry AMD patients. Topline
data from the pivotal LIGHTSITE III study (148 eyes; 24-month study design) has met the primary
efficacy endpoint demonstrating a statistically significant benefit between PBM and Sham
treatment groups, p = 0.003. In addition, a mean 5.5 letter change increase from baseline in visual
acuity was seen in the PBM treatment group, P < 0.0001.
The current SBIR phase IIB application is to extend the findings from previous SBIR phase I and
II studies (SBIR 1R43EY025508-01 and SBIR 1R43EY025508-03) to conduct an open-label,
prospective, multi-center extension study in patients that are exiting the main LIGHTSITE III
study. The extension will continue to assess the long-term PBM impact on disease progression,
safety, and efficacy in subjects with dry AMD (LIGHTSITE IIIB) using Valeda. The study will
also be able to compare and establish PBM benefits of early treatment versus delayed treatment
by allowing extended PBM treatment for 3 years or starting PBM treatment after 2 years of sham
treatment. Specific Aims will establish the magnitude of clinical and anatomical outcome benefits
in a longitudinal magnitude for the first time. The grant supports a novel non-invasive, non-
pharmaceutical, cost-effective therapy for Dry AMD.

Public health relevance
PROJECT NARRATIVE The current grant application proposes to extend the LIGHTSITE III study which is evaluating novel, non-invasive photobiomodulation therapy for the dry form of age-related macular degeneration (AMD). As the population continues to age, degenerative ocular diseases become increasingly common and create a tremendous burden on the health care system. There are ~2 million AMD patients with severe vision loss and another ~8 million AMD patients at risk in the United States alone. There are no approved treatments for dry AMD and, thus it represents a potential high impact, targeted area in medicine.